IMAGING MARKERS OF MYOFIBROBLASTIC DIFFERENTIATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Seeking to image how the actin network and focal adhesion size, as well as collagen secretion (via SHG), of lung fibroblasts change with increasing density of the surrounding ECM.